Support of the North American Association of Central Cancer Registries, Inc. (NAACCR) Annual Scientific Conference

NAACCR Annual Scientific Conference Project Summary R13 20-207
Cancer surveillance data are the lynchpin of the cancer data ecosystem. Only through the collection
of accurate, standardized, curated data on every cancer patient in the U.S. can we truly monitor and
evaluate our progress against cancer. The goal of this application is to convene annual conferences
that will strengthen collaboration between the cancer surveillance community and cancer
researchers to maximize the impact of cancer registries in advancing our scientific understanding.
NAACCR has hosted the most influential and informative annual conference for cancer surveillance
scientists in North America for over 30 years. It is the largest meeting of its kind for population-based
cancer registries to participate in the advancement of cancer surveillance data science, learn new
techniques, exchange information, and develop efficient and cost-effective work practices. This
year, renowned speakers and surveillance experts will highlight changes in cancer care, data
sources, technology, and research requirements and focus on integrating with cancer surveillance
so as to make cancer registries more useful and accessible to researchers.
The objective of this conference grant is to: Convene a conference for cancer researchers, NAACCR
members and the cancer surveillance community to demonstrate the utility and value of cancer
surveillance data in a wide array of cancer research applications, including cancer control, cohort
matching through the NAACCR Virtual Pooled Registry, clinical surveillance,
pharmacoepidemiology, and population-based site specific prognostic indicators. Cancer
surveillance data forms the backbone of countless cancer research studies each year.
The methods used will be the planning and implementation of a world-class scientific conference,
with workshops, break-out sessions, panel discussions, keynotes, plenaries, and posters. In
addition, we plan to encourage attendance and enhance diversity by subsidizing registration for
delegates from under-resourced countries. Awards will be based on need and/or guidelines of NCI’s
Office of Global Health. Due to ongoing uncertainty around travel restrictions and social distancing
measures resulting from the COVID-19 global pandemic, we plan to use a hybrid in-person/virtual
conference model in 2021 and, potentially, subsequent years. Making some portion of the
conference available via an online virtual format allows us to achieve our specific aims while
accommodating the needs of attendees.
The NAACCR meeting is the only cancer surveillance meeting that draws participation from every
state and province in U.S. and Canada. This conference provides an excellent opportunity for
participation by groups that are often under-represented in science, particularly women and
minorities, and the location of the conference is selected to ensure a mix of regional, national and
international participation and representation.

Public health relevance
NAACCR Annual Scientific Conference Project Narrative R13 20-207 For more than 30 years, NAACCR has hosted the most influential and informative annual scientific conference for cancer surveillance professionals. Drawing from every state and province in the US and Canada, as well as international colleagues, the NAACCR Annual Conference is attended by over 400 researchers, epidemiologists, and cancer surveillance scientists annually. Developed by and for cancer surveillance professionals, it is the largest meeting of its kind to share research findings, develop innovative methodologies, support cancer research, and ensure a community that is well-informed on advances in cancer care, data sources, technology, and research interests.